Wadsworth Center's Administrative Core for Radiochemical, Microbiological and Chemical Testing for Food Defense and Capability Development

PROJECT SUMMARY Administrative Core The Administrative Core (Admin Core) is the primary point of contact for routing and integrating all activities within the Wadsworth Center's Radiochemical, Microbiological and Chemical Testing Program for Food Defense and Capability Development program. It acts as the conduit for external and internal communications critical to the smooth operation of the FERN program. The focus of the Admin Core will be to facilitate communications between the Wadsworth Center’s Division of Environmental Health Sciences (DEHS), and Division of Infectious Diseases (DID), and those laboratory units involved in food testing. Admin Core staff schedule conference calls with FERN program officers and FDA subject matter experts to: a) guide program staff on sample analyses; b) advise FERN on sample collection, shipping and storage procedures for food analyses; and c) collaborate with FDA FERN as needed throughout the project. Admin core staff organize and make available standard documents including analytical methods and protocols for distribution to FDA and other FERN labs, as needed. Admin core staff assemble the required progress reports.